MOLECULAR MECHANISM FOR THE REGULATION OF C-REACTIVE PROTEIN

The goal of our project has been the elucidation of the molecular events involved in the regulation of the acute phase response in man. We have concentrated our attention on the prototype acute phase reactant, C- reactive protein (CRP). Our development of an in vitro cell culture system to monitor the induction of acute phase protein synthesis has made it possibly not only to determine the extent of de novo CRP synthesis, the type of processing of the protein and the transcriptional level of regulation, but also to determine the types of biological factors responsible for the induction of acute phase reactants. Previously, we found that a protein produced by monocytes induced CRP synthesis. Recently, we found that this protein, referred to as Interleukin-6, is necessary and sufficient to initiate CRP transcription in our cell culture system. We are also determining the cis-acting elements and the trans-acting factors responsible for the regulatory control of acute phase gene expression. We have isolated the upstream promoter region for the CRP gene and have shown that this region confers inducibility. We have identified both positive and negative regulatory elements, which include 2 distal enhancers and 2 proximal IL-6 responsive elements (6RE) flanking a negative regulatory region. Using mobility shift, methylation interference and immunodepletion assays, we have identified the binding sites and the presence of a number of trans-acting factors: NFIL-6, HNF-1, HNF-3 and several Octamer-like factors. Site-specific mutagenesis of the regions of the 2 proximal 6RE revealed that the upstream element was under inducible positive regulatory control while the downstream element was under inducible negative regulatory control. We are attempting to identify and clone these negative regulatory factors and to determine the modifications which may be altering their binding affinity.